Core B (Animal Component)

Core B (Animal Component) -­ Project Summary

All research projects of this Program Project (PP) will rely on the use of genetically engineered mouse (GEM)
models to investigate the roles and mechanism of Nuclear Receptors, transcription factors and their coregulators
in energy and metabolic homeostasis and disease. More specifically, at least 34 GEM mouse lines will be used,
and thousands of male and female mice will be produced by breeding in house during the funding period of this
PP. Therefore, this Animal Component of Core B is essential for the success of this PP by integrating expensive
equipment, advanced technology, experienced personnel and animal resources. As shown by preliminary
studies, Core B has generated/established multiple GEM lines and developed CRISPR-­Cas9-­mediated mouse
gene editing systems. Core B is dedicated to achieving 3 major objectives. Firstly, Core B will use its specialized
expertise, state-­of-­the-­art equipment and adequate facilities to generate GEM lines for all investigators of this
PP. Core B has established the necessary methods to edit the mouse genome by homologous recombination-­
based gene targeting in ES cells or CRISPR/Cas9-­based gene editing in 1-­cell mouse embryos. Core B will
generate all GEM lines needed by the investigators of this PP. Secondly, Core B will provide high quality mouse
services to manage GEM line colonies and produce genotype-­defined and age/sex-­matched mice for all
investigators of this PP. Specifically, Core B will breed and maintain all of the 34 mouse lines used by this PP.
Core B will use our colony expansion protocol to produce large numbers of genotype/age/sex-­matched mice for
experimental analysis. Core B also will perform genotype analysis, super ovulation, embryo and sperm
cryopreservation, and in vitro fertilization services to help the investigators of this PP for managing their mouse
colonies, preserving GEM lines, transferring mouse lines between institutes, and saving animal husbandry
expenses. Finally, Core B will integrate the efficient usage of animal resources by all investigators of this PP.
Because of the large-­scale operation of mouse models and the sharing features of multiple mouse lines among
the projects of this PP, centralized integration of equipment, expertise and valuable mouse resource will be
essential for both scientific success and cost effectiveness. Core B will minimize the expenses of animal
experiments by consolidating the usage and management of equipment, expertise, animal facility, mouse
maintenance and production. In addition, Core B will serve as a resource for execution and technical training in
the use of all animal manipulations needed and oversee the care and use of experimental mice for this PP.

Public health relevance
Core B (Animal Component) - Project Narrative Because the pathways and mechanisms for maintaining energy and metabolic homeostasis are similar between human and mouse, the investigators of this Program Project will extensively use genetically engineered mouse (GEM) models to understand the roles of several crucial gene regulators in metabolic homeostasis and determine their therapeutic value in treating metabolic diseases. This Animal Component of Core B will provide comprehensive mouse services to support the success of this Program Project application.